3D Endosomal Ultrastructure in Cells Expressing NPC

To complement studies being conducted by NIDDK investigators to understand defects in the endocytic trafficking pathway that occur in Niemann-Pick Type C Disease (NPC), we are determining the cellular ultrastructure of endosomal vesicles and endosomal tubules in cultured fibroblasts and chinese hamster ovary (CHO) cells containing wild-type or mutant NPC protein. Cells sectioned to a thickness of 200 to 400 nanometers were analyzed by automated electron tomography in an energy-filtering 300 kV field-emission transmission electron microscope. Double-axis tilt series were collected over an angular range of +/- 70 degrees and three-dimensional volumes reconstructed by weighted back-projection. The reconstructions show multi-lamellar tubules that appear to correlate with late endosomal tubules previously observed in fluorescent light microscopy of labeled cells.